CTSU CORE SUPPORT SERVICES AND THE CTSU ENTERPRISE OF SYSTEMS - TASK AREA II

The Cancer Trials Support Unit (CTSU) streamlines and harmonizes support services for NCI Cooperative Groups' cancer clinical trials for all phases and types including cancer treatment, prevention and control, advanced imaging, and correlative science studies. The CTSU collaborates with the NCI and its funded Multi-Center Organizations (MCOs) to develop and support operational processes and informatics solutions leading to cost-effective solutions that reduce administrative burden on the clinical sites and accelerate scientific inquiry. To meet its mission the CTSU provides both services and informatics applications.